Timing, Reward Processing and choice

Impulsive choices involve trade-offs between amount and delay by delivering smaller-sooner (SS) versus
larger-later (LL) rewards. Impulsive choices occur when individuals frequently choose the SS when it is
suboptimal to do so. Impulsive choices have been identified as a trans-disease process due to their
association with a wide range of diseases and disorders including substance abuse, gambling, obesity,
and attention-deficiVhyperactivity disorder. Impulsive choice can be both a pre-cursor to and product of
maladaptive behaviors. The overarching goal of our research program is to identify the underlying
mechanisms of impulsive choices and target those mechanisms using interventions to promote selfcontrol.
Time discrimination deficits and delay intolerance predicted stable individual differences in
impulsive choice in the rat pre-clinical model. Poor timing and delay intolerance are purported
endophenotypes in attention-deficiVhyperactivity disorder, providing important links with the rodent preclinical
model. Time-based interventions have successfully moderated impulsive choices and improved
time discrimination in rodents. Time-based interventions were most successful in promoting self-control
in the most impulsive individuals. Most importantly, interventions that involved active waiting and that
required time discrimination were most effective, suggesting a causal role for timing processes in the
time-based interventions. Based on the previous results, the timing dysfunction model (TOM) proposes
that impulsive choices arise from distorted timing processes, which may result in imprecise or inaccurate
timing. Dysfunctional timing processes can lead to impulsive choices. Thus, the TOM proposes that
timing processes are a primary candidate for therapeutic interventions. In addition, different
neurobiological mechanisms may be responsible for the different contributions of specific timing
processes to impulsive choices. Aim 1 will demonstrate distinct roles for specific timing processes in
promoting self-control. This aim will confirm the TOM and pinpoint the mechanisms of time-based
intervention effects on impulsive choices for future neuroscientific and translational research. Aim 2 will
assess effects of the interventions on structural connectivity in cortico-striatal pathways, which are prime
candidates for the time-based intervention effects on timing and impulsive choices. This aim will use
diffusion tensor imaging ( Tl) to measure structural connectivity. Aim 3 will use Designer Receptors
Exclusively Activated by Designer Drugs (DREADDs) to depress activity in neurobiological pathways that
are likely candidates for the time-based intervention effects. The three aims will identify specific cognitive
and neural mechanisms of time-based interventions. This research is significant due the critical need for
effective interventions to moderate impulsive choices. As a trans-disease process, impulsive choice has
broad relevance for human health and is of significant relevance to the NIMH mission.

Public health relevance
People make thousands of daily choices and a long-term pattern of regular impulsive choices can lead to serious health challenges. This project will seek to improve lime-based interventions and understand their neural mechanisms. The goal is to reduce impulsive choices to provide effective therapies for improving public health.